Elucidating the molecular and cellular functions of polyamines

PROJECT SUMMARY
Polyamines are small organic compounds with two or more amine groups. These evolutionarily ancient
metabolites are essential for a variety of cellular processes, including cell growth and survival, and are present
at milli-molar concentrations in mammalian cells. Cellular polyamine concentrations are tightly regulated, and
changes in polyamine levels disrupt numerous cellular processes, including DNA compaction, transcription,
translation, autophagy, and stress response. Disruption of polyamine metabolism is also observed in several
diseases. Genetic mutations in polyamine metabolic pathways are linked with learning disability in Snyder-
Robinson syndrome and are a known risk factor for Parkinson's disease. Polyamine levels are elevated in many
cancers, and there is enormous interest in using this pathway as a chemotherapeutic target. Mechanistically,
how disruption of polyamine metabolism affects cell function and produces disease is not known. The precise
biochemical functions of polyamines in the cell remain mysterious. This gap in our knowledge stems from intrinsic
technological difficulties in probing polyamines.
This project will deliver new methods and conceptual frameworks to elucidate the molecular functions of
polyamines. One, we will develop new quantitative assays to measure polyamine concentrations in living cells.
Two, we will investigate how mammalian cells maintain polyamine homeostasis and identify the proteins involved
in their uptake. Third, we will examine how changes in cellular polyamine levels affect RNA localization, structure,
and translation. By delivering new technologies and functional frameworks, this work will advance our
understanding of the roles of polyamines in the cell, and may help unlock the pharmacological potential of these
metabolites in health and curing disease.

Public health relevance
PROJECT NARRATIVE Polyamines are small organic cations that are found in all living organisms. Polyamine levels are dysregulated in multiple diseases, including cancer, but their precise molecular functions are not understood. We will develop and apply new technologies to understand the role of polyamines in cell function and disease.